Cell Biology Core

CELL BIOLOGY CORE
Abstract
The goal of the Cell Biology Core is to make available to members of the Yale DRC the instrumentation,
technical personnel, and expertise for the analysis of cell function in areas of research related to diabetes. The
Core focuses on molecular and cellular imaging techniques and on analysis of islet cell function. Imaging
methods include light and electron microscopy, and quantitative infra-red imaging of gels and multiwell plates.
Emphasis is given to immunocytochemical methods and to the dynamic light microscopy imaging of living cells
containing fluorescent markers, using standard epifluorescence, total internal reflection, and confocal
(including spinning disk) techniques. In addition, the core offers leading edge techniques such as electron
microscopy tomography and three different types of super-resolution microscopy (stimulated emission
depletion, single-molecule switching nanoscopy, and structured illumination microscopy). DRC investigators
will be trained in various imaging techniques as required for their work. The islet cell biology component of the
core offers isolation of islets, high-throughput parallel perfusion of islets, and dynamic studies of hormone
secretion. As well, the Core offers high resolution respirometry of islets and other cell types or of isolated
mitochondria. It is anticipated that the services provided by the Core will permit the elucidation of wide-ranging
aspects of cell function that are critical to understanding diabetes pathophysiology.